The Impact of Injury-Associated Anemia and its Treatment on Fracture Healing

Project Summary
78.2 million lower extremity fractures occurred globally in 2019, of which 5-10% resulted in delayed or failed
healing. Further, fractures with vascular injuries have poor healing at higher rates (up to 46%), emphasizing the
importance of oxygen delivery to the injured region during healing. Recent clinical studies found injury-associated
anemia—hemoglobin (Hb) < 12 g/dL—is present in ~95% of lower extremity orthopaedic trauma patients. Due
to decreased Hb, anemia is characterized by lower tissue oxygenation levels and increased systemic
inflammation, both of which are linked to impaired bone healing. While blood transfusions remain the current
standard of care for injury-associated anemia, they demonstrate less than 1% efficacy, whereas intravenous iron
therapy (IVIT) achieves ~80% success in chronic anemia cases but remains unexplored in orthopaedic trauma
management. To determine the impact of injury-associated anemia on bone healing, I developed a novel murine
model of femur fracture with injury-associated anemia. Using this model, I demonstrated that moderate anemia
(7 < Hb < 12 g/dL) reduces regenerating bone volume after injury, suggesting that anemia contributes to impaired
bone healing. However, the underlying cause of impaired bone healing in the presence of injury-associated
anemia and how to manage injury-associated anemia after injury have not been studied. Thus, the overarching
objective of this study is to identify how injury-associated anemia affects bone healing processes and
determine if IVIT treatment can facilitate successful bone healing. First, I will determine the impact of injury-
associated anemia on temporal inflammation, hypoxia, and bone regeneration following fracture. In the second
aim, I will establish the efficacy of IVIT in facilitating bone regeneration via resolution of orthopaedic injury-
induced anemia. The research outcomes of this work will 1) provide insight into the biological effects by which
injury-associated anemia impedes bone regeneration and 2) inform the translation of IVIT into the orthopaedic
clinical setting to support bone healing. This work will inform clinicians on how management of injury-associated
anemia can improve patient care after orthopaedic trauma. The proposed studies will be performed at Oregon
Health and Science University, a world-class training environment with strong clinical collaborations. Drs. Karina
Nakayama (sponsor) and Nick Willett (co-sponsor) have developed a comprehensive training plan to support my
professional and technical development including skills in mentorship and scientific communication in addition
to technical skills including multiparameter flow cytometry and dimensionality reduction techniques for
multivariate analysis. Drs. Nakayama and Willett are engaged mentors with expertise in the research of
musculoskeletal injuries and treatments. Dr. Willett offers access to cutting-edge biomedical innovation and
collaborations at the University of Oregon. Dr. Nakayama, Dr. Willett, and my established history of productive
collaboration through routine in-person and virtual meetings will ensure this proposal’s success. This research
setting and their expert guidance will enable collaborative, impactful, & innovative research.

Public health relevance
Project Narrative Lower extremity orthopaedic trauma results in injury-associated anemia in over 95% of patients, and the current standard treatment, blood transfusion, is ineffective at restoring healthy hemoglobin levels after injury in more than 99% of affected patients. Using a novel murine model of femur fracture with concurrent injury- associated anemia, I demonstrated that moderate anemia reduces regenerating bone volume after injury, however, the underlying cause of impaired bone healing and treatment for injury-associated anemia after trauma have not been studied. This proposal aims to investigate the impact of injury-associated anemia on temporal tissue inflammation and hypoxia and evaluate intravenous iron therapy (IVIT) as a potential therapeutic intervention to provide novel insight into how management of injury associated anemia can improve patient care after orthopaedic trauma.